Characterizing the functional heterogeneity of the mouse paralaminar nucleus

PROJECT SUMMARY/ABSTRACT
The development of the amygdala includes an increase in size and cell number during adolescence, which is
thought to confer maturation of emotional and social behaviors before adulthood. Perturbations in this process
are associated with neuropsychiatric disorders and behavioral pathology; yet the cellular components of
adolescent amygdala development are unknown. In humans, the paralaminar nucleus of the amygdala (PL)
contains a large population of immature excitatory neurons that delay their maturation until adolescence. The PL
may be a major contributor to adolescent amygdala development, but the physiology and connectivity of the
region is yet to be investigated. Our recent work has shown the existence of an orthologous population in the
mouse amygdala, opening a tractable model system to study the PL in detail. My initial electrophysiology
experiments indicate putative physiological subgroups within the adult mouse PL. Based on past primate studies
and the Allen Mouse Brain Connectivity atlas, inputs to and outputs from the adult PL may also show diversity.
The goal of this proposal is to define the functional identity of the adult PL by classifying intrinsic electrical and
morphological neuronal subtypes, dissecting their synaptic input patterns, and mapping their outputs. The
training proposed in the advanced techniques of viral tracing, light sheet microscopy, whole-cell patch clamp,
optogenetics, and morphological reconstruction will facilitate the exploration into the functional phenotypes of
mouse PL neurons. These proposed studies are crucial to understanding the role of the PL in amygdala function
and behavior, as well possible involvement in neuropsychiatric disorders.

Public health relevance
PROJECT NARRATIVE The goal of the research proposed in this fellowship is to determine the functional heterogeneity of neurons in the paralaminar nucleus (PL), an understudied region of the amygdala implicated in neuropsychiatric disorders. The experiments will use a mouse model to classify the diversity of mature PL neurons by linking their physiological properties, morphological features, and input/output circuitry. The results will provide crucial knowledge for understanding the role of the paralaminar nucleus in amygdala function and behavior.